Polyamine-stimulated stem cell recruitment in arsenic-induced skin cancer

? DESCRIPTION (provided by applicant): Exposure to arsenic via the drinking water is a global (including in the US), major public health problem, causing neoplasias of the skin and to a lesser extent in other tissues. It is likely that wound-associated inflammation plays a role in arsenic-induced skin tumorigenesis, particularly since arsenic-induced keratoses and tumors tend to be located at sites of friction and trauma not receiving maximum sunlight exposure. However, the mechanisms contributing to arsenic-induced cancer are complex and elusive, largely due to the lack of predictive animal models. Arsenic is a transplacental carcinogen in humans that appears to target keratinocyte stem cells (KSC) leading to dysregulation of the normally tightly regulated process of stem cell self-renewal and differentiation. Because carcinogen target cells are thought to be long lived, slowly cycling KSCs found in the hair follicl bulge region, it is essential to understand pathways that regulate KSC recruitment in skin carcinogenesis. Compelling recent data from our lab show that elevated levels of polyamines stimulate the recruitment of bulge stem cells in quiescent skin. Polyamines are amino acid-derived polycations that are required for cellular proliferation and for a wide variety of physiological functions such as signal transduction, gene expression, and ion channel function. A hallmark of tumor promoting activity involves the induction of ornithine decarboxylase (ODC), the initial rate-limiting enzyme in polyamine biosynthesis. Use of transgenic mouse models has demonstrated that increased ODC activity is sufficient to promote tumor development following a single low dose exposure to a carcinogen. We show for the first time that only in utero exposure to low levels of arsenic in the drinking water causes skin tumors in adult K6/ODC transgenic progeny mice. The Toll-like receptors (TLRs) are important modulators of inflammation, and TLR4 and its downstream adaptor protein MyD88 are required for DMBA/TPA skin carcinogenesis. We show an enrichment of TLR4 expression in bulge stem cells in mouse telogen phase skin and that increased keratinocyte polyamine levels (a cell stressor) induce release of HMGB1, a ligand and potent activator of TLR4. If arsenic exposure leads to an aberrant accumulation of bulge stem cells, then we hypothesize that polyamine- induced HMGB1 release in the epidermis activates TLR4 signaling in bulge stem cells, resulting in their mobilization out of the bulge region, stimulation of inflammatory cytokines, and promotion of arsenic- initiated skin cancer. We propose Aim 1) to investigate the effect of polyamines on bulge stem cells in arsenic-induced skin tumorigenesis and in stimulating recruitment of bulge stem cells into arsenic-induced skin tumors using GFP transgenic reporter mice for permanent labeling and lineage tracking of bulge stem cells and their progeny; and Aim 2) to evaluate the contribution of TLR4 signaling in polyamine-promoted/arsenic- induced skin tumorigenesis and inflammation using mice deficient in TLR4 and with human keratinocytes transformed with arsenic and primary keratinocytes isolated from mice exposed in utero to arsenic.

Public health relevance
PUBLIC HEALTH RELEVANCE: Exposure to arsenic via the drinking water is a widespread and a major public health problem associated with an enhanced risk of various cancers, particularly skin cancer. Although epidemiological association between chronic arsenic exposure and skin cancer is strong, the mechanisms contributing to arsenic-induced cancer remain elusive. We will investigate a novel mechanism for the development of skin cancer in adult animals following fetal arsenic exposure via the mother in order to identify targets for new therapeutic interventions to prevent and/or treat arsenic-induced inflammation and cancer in the skin.